DYNAMO?Diabetes in Youth and Young Adults of the Pacific Northwest

Project summary
Type 1 and type 2 diabetes mellitus (T1D, T2D) continue to rise in youth and young adults (YYA) worldwide,
with disproportionately high rates of T2D among historically underserved populations. Young people with
early-onset diabetes face decades of managing a complex chronic disease and are at heightened risk of
complications. Despite advancements, key knowledge gaps persist regarding trends in early onset T1D and
T2D incidence, disease management, and outcomes in real-world settings, particularly for young adults, rural
communities, and those receiving care outside specialty centers. The transition to adulthood, which often
involves changes in residence, employment, and insurance, complicates surveillance through traditional
methods. To address these challenges, we have brought together a highly collaborative, multi-institutional
team of endocrinologists, biostatisticians, epidemiologists, nephrologists and informaticists with experience in
diabetes surveillance and electronic health record-based research. We have established a unique regional
network of five major health systems across the Pacific Northwest (PNW) to conduct comprehensive diabetes
surveillance in YYA. This network includes Seattle Children’s Hospital, University of Washington Medicine,
Providence Health System, Virginia Mason Franciscan Health, and the Veterans Affairs VISN 20 region,
collectively serving diverse urban and rural populations across Washington, Oregon, Idaho, Montana, and
Alaska. By integrating EHR, claims data, and established research infrastructure, we will conduct systematic
surveillance of diabetes incidence, prevalence, clinical management, and complications in YYA. Our central
hypothesis is that tracking diverse demographics, including rural and Native populations, will uncover critical
disparities in the diabetes burden, healthcare delivery, and outcomes amenable to targeted interventions. Data
will be harmonized across the health systems in our network. We will contribute to and implement the shared
protocol developed with other funded sites in this cooperative grant mechanism. This project will deliver the
first large-scale, real-world surveillance system for YYA with diabetes in the PNW, capturing underrepresented
populations and addressing a pressing need for timely data on evolving trends in care and outcomes. By
systematically identifying disparities in disease burden and clinical management, results will inform
interventions to prevent disease progression, reduce complications, and improve long-term quality of life. The
focus on rural and Native populations ensures that our approach is inclusive, contextually relevant, and poised
to directly influence public health efforts in regions often overlooked by surveillance studies.

Public health relevance
Project narrative Type 1 and type 2 diabetes are increasingly affecting youth and young adults, who must manage this complex chronic disease and its elevated complication risks while navigating critical life transitions such as changes in health insurance, education, employment, insurance, residence, and family planning. To comprehensively understand early-onset onset diabetes, we will conduct surveillance across five diverse Pacific Northwest health systems, spanning specialty and community settings in both urban and rural areas, with particular attention to underserved populations including Alaskan Native and Pacific Northwest American Indian communities. Our study will examine prevalence, incidence, complications, and real-world management of diabetes in these young populations to inform more effective interventions and support systems.